Characterization of multilineage definitive hematopoietic progenitors from human pluripotent stem cells

PROJECT SUMMARY / ABSTRACT
Hematopoietic stem cells (HSCs) are stem cells that replenish the entire suite of blood cells needed throughout
adult life, and are an important source for cell replacement therapies and disease modeling studies. The overall
goal of our research is to understand how to derive these important cells, in a petri dish, from human pluripotent
stem cells (hPSCs). While the signal requirements for this remain unclear, we have recently uncovered a novel
differentiation approach, yielding CD34+ progenitors that harbor both transcriptional and functional properties
that are similar to nascent HSCs. This methodology employs stage-specific retinoic acid (RA) signaling, and
yields a population of cells capable of homing to recipient bone marrow, and give rise to differentiated progeny.
We hypothesize that this population is unique, and a precursor to the HSC that requires additional signals during
its specification, to confer self-renewal capacity. We will test this hypothesis across 2 Specific Aims. In Aim 1,
we will characterize the transcriptional and signal dependencies for the development of these cells, and
understand the role of differential splicing in a critical transcription factor. In Aim 2, we will define the translational
potential of the lymphoid cells that can be obtained from hPSCs, via RA-dependent and RA-independent
mechanisms. The objective of these studies is to understand the development and regulation of HSCs from
hPSCs, and whether HSC-independent lymphoid cells may be a viable alternative source for adoptive
immunotherapeutics. This is of fundamental importance to both basic and translational biology, and the insights
generated from these studies will have clinical implications. Our unique cellular and molecular tools, combined
with our expertise in hematopoiesis, stem cell biology and bioinformatics puts us in an ideal position to make a
significant impact in this field.

Public health relevance
Project Narrative / Relevance Human pluripotent stem cells have the capacity to give rise to any other cell type found in the body, including blood forming stem cells and their derivative immune cell progeny. The goal of this proposal is to understand how these processes occur, and, if the blood cell types obtained are functionally distinct from donor-derived sources. This will allow for technology development to scalably generate each of these blood cell types from a patient’s own cells.